Remote Monitoring of Management of Chemotherapy induced Peripheral Neuropathy

Chemotherapy induced peripheral neuropathy (CIPN) is a common and disabling side effect of chemotherapy.
It frequently leads to chemotherapy dose alteration, pain, fall risk, and increased health care costs. Symptoms
are under reported, under treated and treatment often deviates from guidelines despite the opiate crisis. There
is an urgent need for implementation of effective evidence and consensus driven CIPN management.
Studies pairing a chemotherapy related symptom reporting tool with nurse follow up improved 6 month health
related quality of life and cancer survival. During chemotherapy, our studies pairing a CIPN symptom reporting
tool with nurse practitioner (NP) call back resulted in a 75% reduction in CIPN symptoms. (This care model is
called Symptom Care at Home with NP follow up, SCH-NP). The efficacy of this system post chemotherapy
when CIPN symptoms are worst and doctors visits are infrequent remains unexplored. The proposed RCT will
examine SCH-NP treatment during the period of maximal symptoms, utilize a standardized guideline
based care protocol, allow for phone, app and web based symptom reporting and determine efficacy
using neuropathy specific outcomes. The overall goal of this study is to demonstrate the efficacy of a new
care model that facilitates symptom reporting and proactive treatment management to reduce CIPN symptoms.
Specific Aim1: Determine the efficacy of SCH-NP vs. usual care (UC) to reduce post chemotherapy CIPN
symptoms over 12 weeks. We hypothesize SCH-NP will reduce CIPN symptoms measured on the Neuropathy
Total Symptom Score 6 (NTSS6). 358 recently diagnosed CIPN patients will be randomized to 12 weeks of UC
or SCH-NP care. Both groups will report symptoms daily via phone, app or website. The UC group will receive
standard care through their treating physicians. In the SCH-NP group reporting moderate to severe symptoms
will trigger NP call back to provide evidence-based protocolized treatment including medications, self-care
strategies and referrals. Repeated measure analysis of the NTSS6 covariance will be used to compare groups.
Specific Aim 2: Determine the efficacy of SCH-NP vs. UC in improving CIPN specific quality of life and
disability. We hypothesize that compared to UC, SCH-NP care will improve CIPN specific quality of life
(EORTC CIPN 20) and reduce disability (CIPN-RODS) measured by repeated covariance analysis.
Specific Aim 3: Determine the impact of SCH-NP vs. UC on opiate usage and the utilization of available CIPN
therapies. We hypothesize SCH-NP care will reduced opiate use measured by % of subjects on ≥ 50 MME/
day (high risk) and improve CIPN therapy utilization including neuropathic pain med use, time to prescription,
selection of the correct therapy, adequate titration, max drug doses, and total number of CIPN treatments.
This innovative study utilizes a novel technology based model to circumnavigate roadblocks in CIPN care. The
study’s broad impact and substantial significance derive from the model’s ability to deliver care to those in
resource poor areas with reduced healthcare access in their time of greatest need.

Public health relevance
PROJECT NARRATIVE This innovative study utilizes a technology based novel care model to provide timely care to cancer survivors with CIPN in their time of greatest need and strives to improve quality of life while reducing disability and opiate use. It seeks to fill an important gap in knowledge about CIPN care using consensus based guidelines without time consuming face to face encounters. The study has broad potential impact and relevance as this care model can be integrated into health systems encouraging telemedicine, in particular rural or resource poor areas with reduced healthcare access.